SAFETY AND FEASIBILITY OF SINGLE DONOR BLOOD PROGRAM

The goal of the study is to evalute two types of blood donor programs in newborns. The programs will consist of unrelated donors versus biological parent donors.